Axin Stabilization by Novel Small Molecules to Treat Non-alcoholic Steatohepatitis

PROJECT SUMMARY/ABSTRACT
Non-alcoholic steatohepatitis (NASH) affects 12% of Americans due to the growing number of individuals
with metabolic disorders, including nonalcoholic fatty liver disease, obesity, metabolic syndromes, and diabetes.
At present, there are no pharmacological options approved for NASH. Wnt/beta-catenin pathway and adenosine
monophosphate-activated kinase (AMPK) are crucial pathways in regulation of hepatic metabolism. Genetic and
pharmacological evidence supports a benefit by inhibition of Wnt/beta-catenin on hepatic metabolism;
meanwhile, AMPK activation has emerged as a mechanism against NASH. We have synthesized and tested a
novel class of compounds, of which triazole YW1128 showed dual activities of Wnt/beta-catenin inhibition and
AMPK activation via the mechanism of Axin stabilization. YW1128 showed an exciting efficacy against hepatic
steatosis both in vitro and in mice. Based on the chemical structure of YW1128, we recently designed and
synthesized the new lead YA6060. While maintaining the dual activities, YA6060 has exhibited a highly promising
drug-like profile and particularly an exciting efficacy against hepatic steatosis and fibrosis. We also discovered
the tankyrase-binding protein 1 (TNKS1bp1 or TAB182) as a binding target of our lead compounds. The
proposed studies are intended to test the hypothesis that simultaneously inhibiting Wnt/beta-catenin pathway
and activating AMPK, by stabilizing cellular Axin level via targeting TAB182 with small molecules, is a novel
therapeutic strategy for NASH treatment. To test this hypothesis, we will first synthesize and evaluate new
compounds that inhibit Wnt/β-catenin signaling and activate AMPK, using an iterative process involving new
analog design, synthetic chemistry, in vitro assessment of drug properties, and in vivo pharmacokinetic and
toxicity evaluation. Second, by conducting in vitro and in vivo experiments including ligand binding assays,
genetic knockdown, transgene expression, genetic mutation, chemical inhibition or activation, and various
functional assays, we will determine the mechanism of action for lead compounds in hepatocytes and mice.
Lastly, we will evaluate the efficacy of YA6060 and a new YA6060-based lead compound and validate their
pharmacological mechanism in mouse models with a full range of NASH indications. Successful completion of
this project is expected to establish that small molecules with dual activities of Wnt/beta-catenin inhibition and
AMPK activation via targeting TAB182 and Axin stabilization is a valid resource for the development of NASH
therapeutics. The knowledge and small molecules are expected to greatly benefit future research in
understanding of NASH pathogenesis. Eventually, we expect to transform NASH patient care with a first-in-class
drug.

Public health relevance
PROJECT NARRATIVE Wnt/beta-catenin pathway and adenosine monophosphate-activated kinase (AMPK) pathway play crucial roles in regulation of hepatic metabolism. The proposed studies will develop novel small molecules that possess dual activities of Wnt/beta-catenin inhibition and AMPK activation, delineate their molecular mechanism of action, and assess their efficacy and safety for treatment of non-alcoholic steatohepatitis (NASH) which afflicts 12% of US population. The findings are expected to be of great impact as they lead to pharmacological agents for a highly unmet medical need with no approved drugs.